Administrative Core

ADMINISTRATIVE CORE: ABSTRACT
The Administrative Core (AC) provides the critical leadership and identity role for the CHARTER: (Center for)
Children's Health Assessment, Research Translation, and Combating Environmental Racism. The AC builds
on a strong foundation of academic and research leadership, and a record of accomplishment in research in
children's environmental health and communication science. The purpose of the AC is to provide support for
the overall goals of the Center in the development of effective strategies to translate research findings of
importance to children's environmental health to relevant stakeholders in the community, academia and among
healthcare providers. The AC builds on established outreach and collaboration with communities representing
Black communities impacted by environmental exposure and strong connections with health providers. The AC
will coordinate and integrate all of the components of the overall center and promote activities to assure
smooth communication and coordination. In addition, the AC will represent the center in the CEHRT network
and support the national coordinating center. The AC will work to promote the development of young
investigators in CEH and translation science, particularly emphasizing the support and mentorship of
individuals from underrepresented groups. The outcomes of CHARTER will be monitored through a
comprehensive evaluation strategy to examine the impact of the center on scholarship outputs, translational
science outcomes, and health and societal benefits derived from CHARTER support.